Analytical & Neuropathology

The Analytical and Neuropathology Core provides analytical neurochemistry, gross and microscopic[unreadable] pathology, and tissue, CSF and microdialysate banking for the Program Project. The Specific Aims are: 1.)[unreadable] measure nitrate/nitrite as markers of nitric oxide metabolism in humans and animals following traumatic brain[unreadable] injury (TBI) and in response to erythropoietin (Epo) administration following TBI. 2.) measure Epo and Epo[unreadable] receptor following TBI in humans and animals. 3.) measure biomarkers of inflammation in microdialysate[unreadable] and CSF samples following TBI and in response to Epo therapy. 4.) provide neuropathology support for[unreadable] histopathological analysis of experimental TBI including measurement of contusion volumes, neuronal loss,[unreadable] and antigen expression. 5.) provide tissue and CSF, serum, and microdialysate sample banking for animal[unreadable] and human tissue samples from TBI. 6.) provide analysis of arachidonic acid conversion to epoxygenase[unreadable] products by P450 following TBI in experimental animals. As in previous iterations of the Program Project,[unreadable] the Analytical and Neuropathology Core interacts closely with the major scientific projects and with the other[unreadable] cores.